Overcoming resistance to anti-PD1 immunotherapy

ABSTRACT
Novel immunotherapies for cancer are having a major clinical impact, in particular anti-PD-1 mAbs
which have been FDA-approved for 20 cancer entities. However, the mechanisms that explain
why a subset of patients fails to respond to these therapies is incompletely understood.
Understanding these mechanisms should lead to new therapeutic strategies for expanding
efficacy further. Our prior data indicated that a baseline T cell-inflamed tumor microenvironment
was predictive of response to anti-PD-1, which augments the functionality of CD8+ T cells already
present within the tumor microenvironment. During the previous funding period, we made multiple
novel discoveries that have been paradigm-shifting for the field, which have coalesced to motivate
continued investigation into 5 research directions: investigation of novel T cell immune
checkpoints, innate immune strategies to promote de novo T cell responses in the tumor
microenvironment, tumor cell-intrinsic oncogenic events mediating immune resistance, regulation
of anti-tumor immunity by the commensal microbiota, and germline variants influencing host anti-
tumor T cell responses. Each of these directions is identifying novel therapeutic opportunities
that are expected to expand the circle of efficacy for checkpoint blockade immunotherapy in the
clinic.

Public health relevance
PROJECT NARRATIVE The overall purpose of this proposal is to continue to identify new strategies for cancer immunotherapy based on understanding the molecular features of the T cell-inflamed and non-T cell-inflamed tumor microenvironment. Our overall approach centers on a bi-directional work flow between patient outcomes and clinical samples, and mouse models for mechanistic understanding. Our 5-pronged research stream investigates novel T cell immune checkpoints, innate immune strategies to promote de novo T cell responses in the tumor microenvironment, tumor cell-intrinsic oncogenic events mediating immune resistance, regulation of anti-tumor immunity by the commensal microbiota, and germline variants influencing host anti-tumor T cell responses.